UC Irvine AD Translational Center for Disease Model Resources-Spatial Transcriptomics Supplement

Project Summary/Abstract Neurodegenerative disease mechanisms encompassing Alzheimer’s disease (AD) are complex and have remained largely unknown to date despite the identification of risk factors and genetic mutations associated with the disease. One of the major goals of the UC Irvine MODEL-AD project is to characterize rigorous, reproducible and translatable animal model studies of Alzheimer’s disease (AD), the most common form of neurodegenerative dementia. In this respect, the deep characterization of mouse models of AD using high throughput gene-expression studies at bulk (RNA-seq) and single-cell resolutions (single-nuclei RNA-seq; snRNA-seq) have the potential to unravel novel biology and define drivers of the disease, which is of great therapeutic value. However, current bulk and single-nuclei transcriptomics approaches lack the ability to encode spatial, brain region-specific information, which are crucial to decipher gene-expression changes in the local environment and address long standing questions on how expression of neuronal and glial genes changes during progression of AD-related pathology. The current project represents a major advance in the field by taking a comprehensive approach to data-driven discovery to identify spatial organization of resident neural cells and how they change during the progression of AD. Finally, the project will identify shared transcriptomic signatures between human and mouse model systems in a spatially-resolved manner.

Public health relevance
Project Narrative This project leverages advances in genomics and genetics to understand molecular mechanisms underlying neurodegenerative diseases like Alzheimer’s disease and define brain region specific changes that are altered in disease progression. This supplement will enable region-specific transcriptomic changes and how they alter during the progression of disease. Using multiple layers of genomics data from human and mouse samples, we develop a framework for integrative study of neurodegenerative diseases.